Molecular studies of neural histone monoaminylation in normal and aberrant brain plasticity

PROJECT SUMMARY
Monoaminergic systems in the brain play critical roles in the regulation of a wide variety of neural processes,
and are heavily implicated in the etiology of numerous mood-related disorders in humans, including major
depressive disorder (MDD). While mood disorders are highly heritable, it is clear that environmental factors also
contribute significantly to disease, with chronic stress representing one of the most common precipitating
factors for mood-related diagnoses. In recent years, persistent stress-induced alterations in gene expression
have been demonstrated to promote physiological alterations implicated in mood disorders, and more recently,
histone mechanisms affecting cell-type and regional specific chromatin structures have been causally linked to
the regulation of transcriptional programs that contribute to stress-mediated behaviors in preclinical rodent
models, as well as their responses to antidepressants (ADs). However, our understanding of how these
mechanisms mediate neural dysfunction in response to stress remains limited, and mechanistic connections
between altered monoaminergic signaling and resulting chromatin regulatory phenomena have remained
elusive. Our lab recently identified and mechanistically characterized histone proteins as novel substrates for so-
called monoaminylation in brain, a novel class of post-translational modification that contributes significantly to
gene expression in the central nervous system. In addition, we have observed that H3 monoaminylation states
are perturbed in postmortem brains of individuals diagnosed with certain psychiatric disorders related to
monoaminergic dysfunction (e.g., MDD), as well as in brains of pre-clinical rodent models for the study of these
disorders, phenomena that contribute importantly to transcriptional, physiological and behavioral deficits in these
models. We have also recently identified the protein NQO2 as the bona fide “reader” of H3 serotonylation
(H3Q5ser) in vivo. Since our previous data indicated aberrant roles for H3Q5ser accumulation in brain of
chronically stressed male and female mice as an important contributor to stress-mediated transcriptional and
behavioral plasticity (an effect completely reversed by chronic fluoxetine treatments), we now hypothesize that
NQO2 recruitment to loci displaying elevated H3Q5ser enrichment in response to stress may contribute
importantly to transcriptional programs that result in persistent stress susceptibility. These phenomena, when
attenuated by blockade of NQO2’s ability to bind to H3Q5ser, may then result in therapeutic outcomes, and may
further help to explain the mechanistic actions of traditional ADs. Here, we thus aim to: (1) mechanistically
characterize NQO2’s biochemical/molecular impact on H3Q5ser function in vitro (within a nucleosomal context)
and in cells; (2) rigorously characterize the cell-type specific impact of NQO2-H3Q5ser interactions on stress-
mediated transcriptional and behavioral plasticity in mice; and (3) elucidate the diversity of the neural
monoaminylome via implementation of novel, monoaminylation specific probes to biorthogonally label and
interrogate the full repertoire of serotonylated proteins in brain impacted by chronic stress and AD exposures.

Public health relevance
PROJECT NARRATIVE Monoaminergic systems in the brain play critical roles in the regulation of a wide variety of neural processes, and are heavily implicated in the etiology of numerous mood-related disorders in humans, including major depressive disorder (MDD). While mood disorders are highly heritable, it is clear that environmental factors also contribute significantly to disease, with chronic stress representing one of the most common precipitating factors for mood-related diagnoses; however, little remains known concerning the precise molecular mechanisms mediating mood disorder/stress vulnerability or individual responsiveness to antidepressants. This proposal thus aims to comprehensively examine a novel molecular mechanism recently implicated in stress vulnerability and MDD – i.e., histone H3 monoaminylation in brain, a protein modification discovered and characterized by our laboratory – with respect to its contributions to cell-type specific transcriptional plasticity and its roles in the mediation of stress susceptibility and/or antidepressant efficacy.